MYCOBACTERIAL INFECTIONS IN THE ACQUIRED IMMUNODEFICIENCY SYNDROME

To examine the phagocytosis and killing of mycobacterium avium in alveolar macrophages and to determine the effects of such uptake and killing on other macrophage functions such as cytokine expression.